Circadian disruption and cardiometabolic risk during the transition from adolescence to young adulthood

PROJECT SUMMARY/ABSTRACT
The transition from adolescence to young adulthood is a period marked by multiple physical and behavioral
changes that could impact long-term cardiometabolic disease risk. Changes in circadian rhythm are a normal
part of the pubertal transition but at the extreme may result in circadian disruption, which is the non-optimal
biological timing of sleep, eating, physical activity, or irregularity in their timing. Emerging evidence suggests that
circadian disruption is linked to poor cardiometabolic health, potentially through alteration of circadian gene
regulation. Further, the literature and preliminary evidence suggests that relationships of circadian disruption and
cardiometabolic health are nuanced and may depend on important effect modifiers including sex, chronotype,
and sleep disordered breathing (SDB). Specifically, females and individuals with late chronotypes (a genetically-
driven preference for late sleep/wake behaviors) may be more likely to experience poor cardiometabolic health
in response to circadian disruption. Additionally, SDB is a known risk factor for adverse cardiometabolic health,
and our preliminary cross-sectional evidence suggests it is an effect modifier of the relationship between
circadian disruption and high blood pressure. Building upon this strong foundation of prior knowledge and
preliminary evidence, the present grant is designed to test the central hypothesis that persistent circadian
disruption, including misaligned sleep, eating, and activity timing, will be related to development of
cardiometabolic risk from adolescence to young adulthood through epigenetic alterations of circadian genes and
will be modified by sex, chronotype, and SDB. To do this, we will leverage existing objectively-assessed
sleep/wake patterns and cardiometabolic health biomarkers collected in >500 participants twice during peri-
puberty (ages 14.5 and 16.5). In Aim 1, we will conduct a follow-up visit during young adulthood (age 26, YA1)
to test the hypothesis that persistent circadian disruption from adolescence to young adulthood will be related to
development of metabolic syndrome (MetS). In Aim 2, we will explore epigenetic regulation of important circadian
and metabolic genes as a plausible mechanism linking circadian disruption with risk of developing MetS. Both of
these aims will consider possible effect modification by chronotype and sex. Finally, in Aim 3, we will conduct
home sleep apnea tests in the YA1 visit as an objective measure of SDB and subsequently evaluate whether
SDB is an effect modifier of circadian disruption and cardiometabolic health relationships during young
adulthood. Overall, the completion of these aims will yield novel insights into the underexplored longitudinal links
between circadian disruption and cardiometabolic health and will bring circadian health-related behaviors to the
forefront as important preventative measures against adverse cardiometabolic health during adolescence and
young adulthood.

Public health relevance
PROJECT NARRATIVE Circadian disruption, the non-optimal biological timing of eating, sleeping, and physical activity, is common during the transition from adolescence to young adulthood and may be related to incidence of metabolic syndrome (MetS). This study will examine circadian disruption and the potential modifiers of sex, chronotype, and sleep- disordered breathing in relation to development of MetS, with circadian gene regulation as a potential pathway. Insights from this study have the potential to bring circadian health-related behaviors to the forefront as important preventative measures against adverse cardiometabolic health during adolescence and young adulthood.